This service is a MicroContract for DMPK Expert services for BPN, HEAL and Biologics. Incumbent is Gene Williams, Ph.D. POP: 07/01/2025 to 06/30/2026. HEAL

NINDS is seeking an executive (senior scientific)-level, industry-experienced drug discovery and development subject matter expert with a background in Drug Metabolism and Pharmacokinetics (DMPK) to provide technical support to the following Extramural Programs:

• The Blueprint Neurotherapeutics Network for Small Molecule (BPN-Small Molecule);
• NIH Blueprint Neurotherapeutics program (BPN);
• Other NIH neuroscience-focused drug discovery and development programs.

The NIH Blueprint for Neuroscience Research, a collaborative framework that includes the NIH Office of the Director and 12 NIH Institutes and Centers that support research on the nervous system, established the Blueprint Neurotherapeutics Network (BPN) as a pipeline between the typical endpoint of NIH-funded research and the beginning of industry drug development. The BPN provides neuroscience researchers with funding and access to a full range of industry-style drug development services and expertise. The program is intended for projects requiring medicinal chemistry optimization and Contract Research Organization (CRO) support through Phase I clinical testing.
“This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.”